Comparability protocol for 22.5 mg tablets (NADA # 141-526)

Project Summary/Abstract
The protocol is to add an additional strength of Laverdia tablets. Successful execution of this
protocol will result in the addition of a 22.5 mg tablet to the existing portfolio of 2.5 mg, 10 mg
and 50 mg tablets. There will be no changes to the manufacturing process or facility currently
approved for Laverdia tablets. Approved analytical procedures will be used to assess and test
the new tablet strength.

Public health relevance
Project Narrative Given the demand for the product since launch we have been evaluating the need for an additional strength for Laverdia tablets. Based on a review on several thousand dogs with lymphoma we calculated the most common sizes currently being used and how we could reduce the number of tablets a pet owner would need to give to provide accurate dosing. The addition of a 22.5 mg tablet will help decrease the number of tablets required at the most common body weights of affected dogs.